2025 Excitatory Synapses and Brain Function Gordon Research Conference and Gordon Research Seminar

Project Summary
This proposal requests partial support for a longstanding, well-attended, and well-received Gordon Research
Conference (GRC) on Excitatory Synapses and Brain Function to be held at Southern New Hampshire
University (Manchester, NH, U.S.A.) from June 8 – 13, 2025. The GRC will be preceded by a Gordon
Research Seminar (GRS), which is organized by and for trainees (graduate students and postdoctoral fellows)
on June 7 – 8, 2025, at the same location.
The 2025 GRC, subtitled "Multifaceted Interactions Between Molecular and Activity-Dependent Mechanisms,"
underscores new emerging themes in the field that emphasize the dynamic interplay between molecular
signaling and neuronal activity in shaping excitatory synapses, which are crucial for the rapid transmission and
long-term storage of information in the brain. This focus aims to shed light on how these interactions define the
development, functionality, and plasticity of excitatory synapses by inviting speakers to exchange their cutting-
edge findings anchored firmly in basic research and extend to investigations on neurological and psychiatric
disorders. Dysfunctions of excitatory synapses can lead to severe consequences, contributing to myriads of
disorders such as autism, schizophrenia, depression, drug addiction, Parkinson’s disease, Alzheimer’s
disease, traumatic brain injury, stroke, and epilepsy. Hence, scientific discussions at the GRC are expected to
generate novel insights into understanding the basic mechanisms as well as the development of potential
therapeutics and interventions to address neurological and psychiatric disorders. While decades of research in
the field have established foundational knowledge about the structure and function of excitatory synapses, the
recent advancements in tools and model systems have opened new frontiers providing opportunities for
renewed discussions and collaborations. The 2025 GRC is organized to enhance the diversity of
representations across gender, age, ethnicity, and geographical location. Such diverse representation in an
inclusive and collegial environment is ripe for open discussions of divergent viewpoints that can lead to the
synthesis of novel concepts. The organizers have planned various activities, such as GRC Power Hour and
various mentoring/networking venues, to enable a collegial and respectful exchange of ideas and promote
interactions that can lead to new collaborations across disciplinary boundaries.

Public health relevance
Project Narrative Excitatory synapses are fundamental for normal brain functions, including sensation, coordination of movements, emotions, social interactions, decision-making, and learning and memory. As such dysfunctions of excitatory synapses lead to a wide range of neurological and psychiatric disorders. The 2025 GRC will invite leading scientists across disciplines to exchange novel concepts on how excitatory synapses are regulated by molecular signaling and activity, as well as new mechanistic understandings of their dysregulation in neuropsychiatric diseases.